Coupled Transfers of Electrons and Protons

Project summary/abstract
Supplemental funding is requested for a new Perkin Elmer diode array UV/Vis/Near-IR
spectrophotometer with multi-sampler and sample temperature control. Our laboratory
has relied on HP/Agilent 8453 UV-Vis diode array spectrophotometers for at least two
decades, for this project and others. Both of our old HP/Agilent 8453 UV-Vis diode array
spectrophotometers have now stopped functioning, and Agilent no longer services or
makes parts for these workhorse instruments. We currently have two UV/vis
spectrophotometers, but these are scanning instruments that are slow to obtain a whole
spectrum and they are set up with fiber optic cables to obtain optical spectra inside of
glove boxes. The rapid scanning of the diode array, the temperature control, and the multi-
sample capability will accelerate the current and planned research projects supported by
this award. These projects use molecular and colloidal nanoparticle systems to develop
understanding of fundamental chemical processes, especially proton-coupled electron
transfer and oxygen atom transfer, which play important roles in biological systems.

Public health relevance
Project Narrative The goal of this project is to develop fundamental understanding of proton-coupled electron transfers and oxygen-atom transfer chemical reactions that are relevant to biology. For many years this work has relied on rapid-scanning diode array spectrophotometers, but our two old instruments of this type have stopped working and are no longer repairable. The requested UV/vis/near-IR spectrophotometer will complement our existing scanning instruments, allowing different and valuable experiments.